Developmental Research Program

DEVELOPMENTAL RESEARCH PROGRAM (DRP) SUMMARY/ABSTRACT
The objective of the Developmental Research Program (DRP) of this SPORE planning study is to support the
development and successful completion of innovative, high-risk/high-reward pilot projects that aim to
understand or reduce outcome ethnicity-based disparities in childhood acute lymphoblastic leukemia (ALL).
This program will be co-led by Dr. Maria Monica Gramatges, a physician scientist, and Dr. Philip Lupo, a
molecular epidemiologist. Drs. Gramatges and Lupo each have strong track records in translational research
investigating genetic and molecular predictors of treatment-related toxicities in childhood cancer. Their
complementary disciplines and history of collaboration evidence a strong commitment of the DRP to supporting
multidisciplinary research. DRP-supported projects may be clinical or translational, but must address ethnic
disparities in ALL treatment-related toxicities (acute or late onset). Eligibility to apply for a DRP Pilot Grant will
extend to any faculty member of an institution participating in this application. Proposals will be scored using
the NIH 9 point system, and selection for funding will be jointly determined by the DRP Committee.
Membership to the DRP Committee will be distributed equally across all participating sites to ensure equity and
transparency in award distribution, and will include faculty with expertise in clinical and translational research
and who have a strong track record of participation in grant peer review. Criteria for funding will be work with
strong scientific merit that is perceived as high-risk/high-impact in the above listed areas of concentration.
Proposals representing collaborations between participating institutions will also be prioritized, as will
proposals from junior faculty and new investigators (those with no prior independent federal funding) and those
considered likely to result in future independent funding. All Pilot Grants will be awarded for one year, with an
opportunity for a one-time, one-year renewal at the end of the first year. In addition to grant review and
selection, the DRP Committee will be responsible for monitoring and oversight of funded projects via regular
review of progress and final reports. The DRP's core mission is to provide grant awardees with 1) funding
support, 2) access to core facilities, and 3) mentorship during the award period. A total of $75,000 will be
budgeted to support funding of three Pilot Awards in Year 1 at $25,000 per award, and $90,000 per year in
each subsequent year to support funding two Pilot Awards per year plus two renewals at $20,000 per renewal.
All Pilot Grant PI's will be provided with access to the designated Cores with no associated cost, and will be
required to use at least one Core. The DRP Committee will assign each funded project an Advisory Committee
with relevant expertise, who will provide mentorship and guidance that is specific to each project. A key role of
the Advisory Committee, together with the DRP Committee, will be to facilitate the transition/development of
Pilot Grant data to work that is independently funded, with potential inclusion in a future P50 application.

Public health relevance
DEVELOPMENTAL RESEARCH PROGRAM (DRP) NARRATIVE The objective of the Developmental Research Program (DRP) of this SPORE planning study is to support the development and successful completion of innovative, high-risk/high-reward pilot projects that aim to understand or reduce outcome ethnicity-based disparities in childhood acute lymphoblastic leukemia (ALL). Funding decisions will be made by the DRP committee, which will consider work with strong scientific merit that is perceived as high-risk/high-impact in relation to ALL disparity research. Additionally, we have assembled a strong Advisory Committee, which together with the DRP Committee, will facilitate the transition/development of pilot grant data to work that is independently funded, with potential inclusion in our future P50 application.